Exposome and Health Equity Conference Series across the Life Course

PROJECT SUMMARY
Meharry Medical College and the Icahn School of Medicine at Mt. Sinai are proposing to co‐host a
five‐year, in‐person, conference series on the Exposome across the Life Course with an environmental
justice lens. This five‐year, conference series will examine the science behind environmental justice.
Year one will promote the use of a child exposome and environmental justice lens in research on child
health and development with a long‐term goal of advancing health equity and environmental justice.
Childhood is a time of rapid growth and differentiation biologically and is radically different than adult
biology and behavior. If the timing of a toxic exposure corresponds to a life stage during which growth is
particularly rapid, the potential impact of that exposure is multiplied by offsetting the developmental
trajectory of the child. For example, low level lead poisoning is most common at age 2‐3 years because
of hand to mouth behavior that is normal at this age. In addition, this age is also the peak of synaptic
pruning in the developing brain, a process by which environmental inputs shape a child's life long
synaptic network of neurons that drive neurocognition and neurobehavior. Children's unique age‐
related patterns of exposure and their developmentally defined windows of susceptibility magnify the
long-term health impacts of environmental injustice. Effectively promoting child health and reducing
disparities in personal and population‐health outcomes requires an understanding of the pathways
through which environmental exposures lead to the onset, progression, and outcomes of disease and
population level disparities. While we cannot do much to change our genes, emerging research shows
that identifying and managing environmental hazards offers the best hope for prevention and improving
population health. This conference will address subsequent life stages (adolescence, young adulthood
(including pregnancy, middle age, and older adulthood) in subsequent years.

Public health relevance
PROJECT NARRATIVE Environmental injustice contributes to disparities in health status across populations of differing ethnicity, race, and socioeconomic status. Infants and children, because of their unique biological vulnerabilities and age‐related patterns of exposure, are especially vulnerable to the health impacts of environmental injustice. This initial conference of a five year series will bring together child exposomics researchers with students and early stage investigators from historically black colleges and universities with community and child health advocates to assess the state of the science and create an environmental justice agenda for children.